Harmonizing Hospital-Based Violence Intervention Programs with a Novel Medical-Legal Partnership for Equity in the Social and Structural Determinants of Health – the HVIP-MLP Model -- Supplement

Project Abstract:
Parent Grant: Trauma center verification requires injury prevention efforts, often in the form of Hospital-
based Violence Intervention Programs (HVIPs). Limitations exist in how well they address the Structural &
Social Determinants of Health (SSDOH) that lead to violence. Medical-Legal Partnerships (MLPs) address the
SSDOH of patients, by connecting legal & medical experts to improve health outcomes. No MLP exists to
date in a trauma center, incorporated into HVIP activities. In our biphasic proposal, our UG3 aims are to
identify the SSDOH of our firearm injured patients after creating & implementing the HVIP-MLP model into our
South Side trauma center. Our UH3 aims examine implementation & clinical outcomes, including trauma re-
injury. This novel HVIP-MLP approach may enhance the HVIP injury prevention model in trauma centers to better
support patients, families & communities in their recovery & prevention of future firearm injury. Proposed
Supplement: One challenge with our HVIP-MLP model is the standardized screening of all patients,
regardless of age. Our preliminary data indicate that firearm- injured youth have unique SSDOHs that are
different from those of adults. This is a crucial distinction since firearm injury is the #1 cause of mortality for
youth <20 years. If we do not understand the unique SSDOH of our youth, our HVIP-MLP intervention may
be of limited impact in the most vulnerable group affected. Similarly, burnout is a significant concern for our
Violence Recovery Specialists (VRS) who work in our HVIPs. Also affected by a history of trauma, VRS are
credible messengers from violence-affected communities, and often experience vicarious trauma when
caring for violently-injured patients from the same communities. MLP resilience & empowerment may
counteract burnout experienced by VRS, but this has not yet been studied. In this Supplement we propose
a mixed-methods approach to determine the impact that our HVIP-MLP model has on firearm-injured
youth and our VRS, representing vulnerable populations in both the patient & provider spheres of
care. In Aim 1, we will understand the specific SSDOH of firearm-injured youth compared to adults. In Aim 2,
we will measure the impact of the HVIP-MLP model on the vicarious trauma, resilience & empowerment of
our VRS. Appreciating that the upstream SSDOH are related to firearm violence, Aim 3 will center on
engaging in research-to-action policy change. With the initial 1-year Supplement (extending into year 2 after
UH3 transition) our candidate will gain skills in mixed-methods research & submit a K application using pilot
data from this Supplement.

Public health relevance
Project Narrative: Incorporating Medical-Legal Partnerships (MLPs) into Hospital-based Violence Intervention Programs (HVIPs) is a unique mechanism for trauma centers to address the Social and Structural Determinants of Health (SSDOH) upstream to community-level firearm violence. The unique impact this novel intervention has specifically on firearm-injured youth and the Violence Recovery Specialists who care for them, is unknown. In this study, we propose a mixed-methods approach to determine the impact that our HVIP-MLP model has on both trauma- affected groups, representing vulnerable populations in both the patient & provider spheres of care.